All of Us at the Baylor-Hopkins Clinical Genome Center

The Baylor-Hopkins Clinical Genomics Center (BHCGC), comprised of teams at the Baylor College of Medicine Human Genome Sequencing Center (HGSC), John’s Hopkins University Center for Inherited Disease Research (CIDR) and the University of Texas School of Public Health (UTSPH), will provide short read whole genome sequences (srWGS), genotyping arrays and genetic interpretation for the National Institutes of Health’s All of Us Research Program (All of Us). The BHCGC has so far generated 171,226 genotyping arrays, 154,349 srWGS sequences and populated reports for ~36,000 individuals via 54,349 variant interpretations, with ~1,000 positive findings. For srWGS, the Illumina NovaSeq X platform will be validated for FDA IDE approval, while automated literature scanning will speed and simplify the task of variant interpretation. New tools will be introduced to speed variant re-analysis of All of Us data, so that updated reports can easily be generated. While collaboratively building infrastructure for the All of Us program, the BHCGC has made major contributions, including (i) array choice and design of content, (ii) calibration of the variant interpretation workflow, (iii) collaborative variant harmonization, (iv) to reprocessing of 240,000 array samples and 330,000 srWGS for the All of Us Data and Research Center (DRC), (v) development of the FDA IDE, (vi) identification of sample contamination at the Biobank, (vii) design of all the aspects of sample flow and manifests and (viii) contributing to critical decisions related to overall program management. Each benefited from engagement with the All of Us network, via individual meetings and regular group interactions. Additional Pilot projects are to (i) greatly increase the data from proteomic assays, at minimal cost to the program, (ii) develop an untargeted metabolomic data resource and analysis workflow for the Researcher Workbench (RWB) and (iii) continue long read DNA sequencing assays. Demonstration Projects will pave the way for All of Us completion by (i) defining the pathway to a complete whole genome report, (ii) determining how mixtures of long read data and srWGS can be combined, (iii) provide infrastructure, integrated RWB workflows and illustrative examples of multiomic studies (DNA, methylation, RNA, protein, metabolomic). Driver Projects will (i) analyze ‘missingness’ of All of Us Health Data on the RWB, (ii) analyze extant long read DNA sequence data and (iii) study DNA methylation. The Pilots, Demonstration and Driver Projects together contribute to the final All of Us product.